Coupling of vascular CaV1.2 channels in health and disease

Abstract .
How a given protein organizes into a functional complex in health and disease is particularly relevant for
membrane proteins that serve as key information entry points for cells. A suitable and highly relevant example
is voltage-gated L-type CaV1.2 channels, which play a major role in arterial myocyte function and vascular
reactivity. These channels have been shown to gate in unison (i.e. cooperative gating) to amplify Ca2+ influx. At
present, however, a comprehensive understanding of mechanisms fostering the induction of CaV1.2 cooperative
gating as well as its functional implications in health and disease represent major knowledge gaps. The overall
objective of this proposal is to investigate the requirement and physiological consequences whereby
phosphorylation of a single amino acid – S1928 – in the C-terminal of vascular CaV1.2 channels promotes
dynamic spatial organization of CaV1.2 to facilitate cooperative gating at the surface membrane. To accomplish
this goal, we are testing the central hypothesis that CaV1.2 S1928 phosphorylation tunes dynamic channel
clustering and cooperative gating, and that this contributes to modulate vascular function in response to elevated
extracellular glucose and during diabetes. This hypothesis is formulated on the basis of strong and rigorous
preliminary data revealing an unanticipated and remarkable role for S1928 phosphorylation as the culprit for
redistribution and assembly of CaV1.2 subunits into superclusters at the surface membrane of arterial myocytes
upon elevated glucose and diabetes. CaV1.2 superclusters mediated by S1928 phosphorylation promotes
CaV1.2 cooperative gating and Ca2+ influx amplification into arterial myocytes. Key findings that further
underscore the significance of our observations is that CaV1.2 S1928 phosphorylation is necessary for
activation of prohypertensive signaling pathways, vasoconstriction and altered blood flow upon elevated glucose
and during diabetes. Moreover, critical observations have been validated in freshly dissociated human arterial
myocytes from nondiabetic and diabetic patients, underscoring the translational relevance. Emerging and
innovative concepts that will be explored in this application are the role of S1928 phosphorylation as 1) a
rheostat of CaV1.2 function and vascular reactivity and 2) a major risk factor for vascular complications in
diabetes. A multiscale contemporary approach that includes innovative microscopy techniques, sophisticated
biochemistry, electrophysiology, in silico analysis and unique animal models will be implemented to explore the
following aims. Aim 1 is to elucidate the role of S1928 phosphorylation in dynamic CaV1.2 clustering and
cooperative gating upon elevated glucose. Aim 2 is to examine the requirement of S1928 phosphorylation to
induce CaV1.2 superclustering and cooperative gating in arterial myocytes during diabetes. Results will transform
our understanding of how CaV1.2 are organized in arterial myocytes (and perhaps other cells) in health and
disease and may lay the foundation for novel therapeutic strategies with single amino acid accuracy to correct
channel function and vascular reactivity.

Public health relevance
Project Narrative . Nanoscale organization of proteins is emerging as a critical process controlling cell function in health and disease. The long-term goal of this study is to examine mechanisms underlying the spatial nano-organization and activity of a key protein involved in the regulation of smooth muscle cells that make up the arterial wall during physiological conditions and during elevations in extracellular glucose and diabetes. The study fulfills relevant public health goals and NIH mission by generating fundamental basic knowledge that could help identify and develop novel treatment strategies to address vascular complications during diabetes.